Pilot Project Core

ABSTRACT
The overall goal of the Northeast Ohio Alcohol Center (NOAC) is to identify specific molecular targets responsible
for ethanol-induced tissue damage, as well as to understand the complex adaptive and maladaptive responses
of cells and systems to that damage. This information will enable us to 1) target therapeutic interventions to slow
and/or reverse the progression of alcohol-induced tissue injury and 2) develop specific assays that can assess
the efficacy of novel therapeutic strategies in relevant clinical populations. The NOAC brings together an
outstanding team of interdisciplinary investigators including geneticists, cell biologists, oxidation biochemists,
biomarker experts, synthetic chemists and clinical translational investigators. A critical element to leveraging the
expertise of our team of investigators is to provide support for pilot projects. Pilot projects bring innovative and
promising new approaches to the alcohol field and facilitate collaborations between team members and outside
investigators to build onto their existing individual research programs. Pilot projects are supported by our Animal
and Cell Models Core and Clinical Core, facilitating rapid progress for investigators new to the area of alcohol
research. Importantly, the supportive intellectual environment with broad expertise in biomedical and clinical
investigations will allow for the continued development of novel and innovative pilot projects. Therefore, support
for pilot projects will likely have a large impact on the progress of research on mechanisms and treatments for
ethanol-induced tissue injury. The Specific Aims of the Pilot Projects Core are to 1) Advertise the availability
of Pilot Projects and invite pilot projects from faculty at Cleveland Clinic, Case Western Reserve University,
MetroHealth Medical Center, Northeast Ohio College of Medicine and National Children’s Hospital, organize
their review and ranking, 2) Provide support for junior investigators in implementing their proposals and 3)
Monitor progress of Pilot Projects on a yearly basis. Implementation of the Pilot Projects Core will allow for
funding of novel and innovative hypotheses with a rapid turnaround from conceptualization to actualization,
facilitate collaborations between basic and clinical investigators and provide seed money to test exciting new
approaches to understanding pathophysiology of ethanol-induced tissue injury, as well as development of
biomarkers for disease progression and susceptibility. Importantly, the Pilot Projects Core will also extend the
numbers of participating investigators in the NOAC and continue to build a community able and willing to conduct
cutting edge basic and clinical alcohol-related research.